I: Penn State Institutional Career Development Core

Contact PD/PI: Sinoway, Lawrence Isaac Inst-Career-Dev-001 (002)
5
. & + "& ,! " " & 1 )- $",1 & "%( , ' $"&" $ & ,* &+$ ,"'& $ + " & * + * ! /"$$
!" . 1 * + * ! *+ /!' * ,* "& "& *" '*'-+ * + * ! % ,!' '$' " + & )-"(( ,' & ." ,
( ,!/ 1 *'% +" "+ '. *1 ,' "%(*'. ! $,! ! '. * $$ ' $ ' ,! && , , $"&" $ & * &+$ ,"'& $
" & &+,",-, 3+ &+,",-,"'& $ * * . $'(% &, *' * % "+ ,' $ * , + !'$ * ,* &+","'& ,'
* + * ! "& ( & & -* (*"'*"," + "& $- "& * +"& ,! * " $ ,!&" & + " &," " ". *+",1 ' '-* + !'$ *+
-,"$"2"& "&&'. ,". +,* , " + ,' & & -" + !'$ *+ ,' &! & * + * ! (*' - ,".",1 0, & "&
& % &, "& *-* $ ! $,! * + * ! & * "&"& '-* , *". & '&,"&-'-+ (*' * %% ," "%(*'. % &,
/"$$ * *-", + !'$ *+ /",! '-,+, & "& (', &," $ ,' '% , $1+,+ '* "&&'. ,"'& "& "'% " $ * + * !
,* &+$ ,"'& & ,!"+ (($" ,"'& / ."-1"/0 /1,,+.0 #+. / %+( ./ *! % 2" * &*/0&010&+* ( +))&0)"*0
#+. * !!&0&+* ( / %+( ./ $$ * &, -& & "&+,",-,"'& $$1 -& + !'$ *+ /"$$ + $ , ,!*'- !
&". *+",1 /" ! . ++ ,' ,! + % * * . $'(% &, '(('*,-&"," + & + % 0( , ,"'&+ '*
(*' * ++ ,'/ * . $'(% &, ' + " &," " "& ( & & ! + $ , + !'$ *+ /"$$ &*'$$ "& & "&, &+".
1 * (*' * % +" & ,' (* ( * ,! & 0, & * ,"'& ' $ *+ "& -* "%+ * ,'
" .1&0 *! "*$ $" 0 ("*0"! / %+( ./ #.+) !&2"./" '$.+1*!/ &* +(( +. 0&2" (&*& ( *!
0. */( 0&+* ( / &"* "/ ."". !"2"(+,)"*0
),(")"*0 * &*0"*/&2" )"*0+.&*$ + %&*$ /0. 0"$3 #+. 1.."*0 *! ." "*0 / %+( ./ 0+ 601.* 0%"
1.2"7 +* / %+( . 0. */&0&+* 0+ &*!","*!"* "
"2". $" 0%" /0."*$0%/ +# +1. 8/ .1. ( "*2&.+*)"*0 , .0*"./%&,/ *! 0" %*+(+$&"/ 0+ !"2"(+,
."/" . % ,. 0& 1) &* .1. ( %" (0%
"#&*" ,.+ "//"/ #+. +((" 0&+* * (3/&/ *! 10&(&4 0&+* +# "2 (1 0&2" ! 0 $1&!"! 3 0%" (+$& )+!"(
0+ #+/0". +*0&*1+1/ -1 (&03 &),.+2")"*0 +# 0%" ."". !"2"(+,)"*0 ,.+$. )
* ' &"2 %-$,"($ ,'*+ '&,*" -, ,' ,! + !'$ *+3 ,* &+","'& ,' "& ( & & "& $- "& ,! "* "&"," ,".
( *+"+, & * +"$" & +-(('*,". % &,'*+!"( "&, * ,"'&+ /",! '$$ '* ,'*+ (*', , * + * ! ,"% & ,!
"&+,",-,"'& $ * + * ! "& * +,*- ,-* & -$,-* "%"& '* %"$ +,'& + '& ,! ( ,! ,'/ * "& ( & & $+'
. *" + ( & "& '& ! "& "." - $3+ (*"'* ,* "&"& -* (*' * %% ," ' *"& + * ''* "& , /",! ,!
* &+$ ,"'& $ & .'*+ '* ,! '%%-&",1 & + * ! '* & ,! (*' * % &
"& $- . & * + '* + %"& *+ 0( *" &," $ '(('*,-&"," + "& "." - $ '-*+ + $ *&"& %' -$ + &
$ 0" "$",1 '* "& "." - $"2 $ *&"& &, & '-, '% + * '%( , &, ,* &+$ ,"'& $ * + * ! *+ /",! +#"$$+ ,'
$ * , "+ '. *1 1 *" "& (+ & "&&'. ,"'& $'& ,! ,* &+$ ,"'& $ * + * ! '&,"&--%
Project Summary/Abstract Page 873
Contact PD/PI: Sinoway, Lawrence Isaac Inst-Career-Dev-001 (002)
5
2""*"3 $2 -/4 +/+ "- $ */ %- -%(+1" -+0, / $6'37/8/43
84 3*+5+3*+3)+ .'6')8+6/78/)7 '3* 98)42+7 4, +3846+* '6++6 +:+1452+38 #).41'67 '8
1/3/)'1 '3* $6'371'8/43'1 #)/+3)+ ;'6* 378/898/437
2""*"3 "-0) ( "* + % $+(. +2-3( ' $+% "-)"&+ -/%*
() *. ) 3+ 1"*,+-/ 0-*$ ) %*!. *%#$/ ++!. %*#.)+-"
%*. 0-# +*# -*"(( *# +(! 2"- ++-" ) "-# $ /-%
. (%' *#- 1%/" *#("3 )42293/8= '5564'). 84 2468'1/8= 56+*/)8/43 /3 7+57/7 :/' -+3+
+<56+77/43 '3'1=7/7 " #
(" *2 ( % 4 - * !+. #.$ 2 $%"*'" ( *' !64248/43 '3*
8+396+ 541/)/+7 ,46 8+'2 7)/+3)+ '8 )411+-+7 7).4417 4, 2+*/)/3+ !
-/%* 0/-%" -! "2%. 7978'/3'(1+ )4967+ /3 6+7+'6). 2+3846/3- !

-.!"* ).+* ,/+* *:4)')= 6/:+7 64;8. 97842+6 *:4)')= 6/:+7 % 97/3+77
64;8. # ! " " & !
0*./"%* +,'918 "91+7 6+ +88+6 $.'3 )8/:+ .447/3- ,8+3 !

0*#$ *. "!"- ")%*#2 3 %))%. +*". "+)69/8/3- 5'8/+387 84 2+*/)'1 6+7+'6).
*49(1+ (1/3* 6'3*42/7+* 86/'1 4, 458 /3 :+6797 458 498 786'8+-/+7
%(1% % " " " " # " # " $ " "
&'7./3-843 2+6/)'3 !7=).414-/)'1 774)/'8/43
+--"./ $".("3 - -"#" - %./-3 +:+1452+38 4, 8.+ +'63/3- +'18. #=78+2
"+7+'6).+6 46+ 425+8+3)/+7 " $ !
+*4 (+ "'$/3 - / -- +-' * -0*"// * $"- -""* -"/$("%* %
2.+* +*- ! 0((%1 * $2 -/4 '+ $"( ' +'18. #=78+27 #)/+3)+ 966/)91' /3
%3*+6-6'*9'8+ +*/)'1 *9)'8/43 *+38/,=/3- '3* +,/3/3- ' !48+38/'1 966/)91'6 6'2+;460

+ %*.+* $2 -/4 % "#(%+ $(02 (% -%(+1" %3*+678'3*/3- '6++6
#9))+77 '3* 87 4386/(98/3- ')8467 ,46 1/3/)'1 '3* $6'371'8/43'1 3:+78/-'8467

#+1 !4591'8/437 %3*+66+56+7+38+* /3 8.+ <86'296'1 #)/+38/,/) &460,46)+
.8857 */:+67/8= 3/. -4: '(498 97 54591'8/43 93*+66+56+7+38+*
References Cited Page 874